Personalized Risk Prediction and Mechanistic Profiling of Cardiac Allograft Vasculopathy

1 PROJECT SUMMARY:
2 Cardiac Allograft Vasculopathy (CAV) is the leading cause of transplanted heart failure and loss. Despite being
3 a major cause of morbidity for heart transplant (HT) recipients, little progress has been made in tailoring CAV
4 surveillance and mitigation strategies to individual patient risk. All guideline-endorsed methods for CAV detection
5 rely on repurposing techniques initially developed for evaluating native coronary artery disease. As such, these
6 techniques focus on estimating the flow of blood through the large, epicardial coronary arteries. Despite the
7 large-vessel focus of established CAV screening, the pathobiology of CAV also involves significant microvascular
8 inflammation, with distinct histologic changes which precede overt, large-vessel manifestations. Currently, there
9 are no objective means for measuring these microscopic changes, forcing clinicians to rely on tests which only
10 detect CAV after it has progressed to macroscopic stages. We hypothesize that the application of digital tissue
11 analysis methods in CAV will lead to both a clinically viable risk-assessment tool, and to the discovery of novel
12 mechanistic biology. Human tissue samples contain a wealth of information which is underutilized in conventional
13 clinical and scientific workflows. However, advanced digital technologies capable of extracting and quantifying
14 the spatial information contained within residual tissues are poised to change this. Computer-aided image anal-
15 ysis of digital pathology (DP) slides can extract novel ‘morphologic biomarkers’, quantifying the sizes, patterns,
16 and spatial relationships which comprise the cardiac microarchitecture. Combining DP morphologic analysis with
17 new, spatial-molecular profiling techniques adds additional insights, enabling deep, mechanistic interrogations.
18 Our team is a leader in cardiac digital pathology (DP) analysis, having developed numerous first-in-heart pipe-
19 lines for generating clinically important diagnoses and risk-assessments. We are also leaders in spatial-molec-
20 ular profiling of human cardiac tissues, with important contributions in both HT and non-HT diseases. As de-
21 scribed in a recent publication in Circulation, we have developed the ‘integrated-CAV Prediction’ (iCAV-Pr) sys-
22 tem. iCAV-Pr uses clinical data and residual tissue from routine post-HT biopsies to predict which patients will
23 go on to develop CAV years before overt disease onset. To fill unmet needs in heart transplant care, we propose
24 a multicenter study aimed at validating iCAV-Pr predictive performance, at establishing it’s potential role in clin-
25 ical practice, and at defining the biology that underlies it’s predictions. In Aim 1, we will enhance the iCAV-Pr via
26 extraction of new morphologic features, followed by performance validation in a diverse, multinational, retrospec-
27 tive cohort. In Aim 2, we will assess the efficacy of iCAV-Pr vs. intravascular ultrasound, the most sensitive
28 existing method for detecting early changes in CAV. And, in Aim 3, we will perform high-plex digital spatial
29 proteomic profiling on serially collected EMB pathology slides to deeply explore the mechanisms underlying CAV
30 development. Successful completion of these aims could open a new frontier in personalized post-transplant
31 care, enabling providers to tailor both CAV screening and treatment strategies to individual patient risk.

Public health relevance
1 PROJECT NARRATIVE 2 Cardiac allograft vasculopathy (CAV) is a leading cause of morbidity and mortality for heart transplant 3 recipients, and cannot be reliably predicted using any existing diagnostic test or risk model. The aim of this 4 investigation is to utilize advanced computational image analysis methods and pre-existing, routinely acquired, 5 endomyocardial biopsy histology slides to validate the iCAV-Pr – a novel tool for predicting CAV years before 6 overt clinical presentation. Beyond multicenter validation of this novel precision diagnostic tool, we will 7 establish the potential clinical role of iCAV-Pr within the diverse landscape of contemporary CAV screening 8 and prevention practices, and will leverage cutting-edge spatial molecular profiling to deeply characterize the 9 immune-biology which underlies the early histologic changes measured by the iCAV-Pr.